Plan to Enhance Diversity

PROJECT SUMMARY – PLAN TO ENHANCE DIVERSITY
The Plan to Enhance Diversity (PED) for the University of Wisconsin Carbone Cancer Center (UWCCC)
constitutes a commitment of resources to enhance diversity of membership, leadership, staff, trainees, and
advisors as a cornerstone to achieving the UWCCC mission and vision to defeat cancer through the rapid
application of groundbreaking research, prevention, and treatment. The UWCCC strives to be a diverse,
equitable, and inclusive community with a pledge to implement policies, trainings, advocacy networks, and
creative programming for that purpose. The UWCCC extends these solutions throughout our cancer training and
oncology education programs, staffing of clinical service lines and research teams, leadership and career
development programs, research groups in all forms of biological and population health sciences, and translation
to patient-centric care. Our PED specific aims are: 1) Establish and monitor metrics for understanding DEI at
UWCCC, and 2) Build and maintain a diverse workforce, leadership team, and advisory boards. PED leaders
provide a track record of academic scholarship, community and stakeholder engagement, and partnership
between the UW and the UW health system. This partnership will facilitate investment in developing and
maintaining a diverse workforce, creating collaborative initiatives, and strategically hiring into DEI pipelines. The
PED leaders will prioritize and steward diversity by creating a UWCCC Diverse Workforce and Equity
Transformation Committee (DWETC) to guide and hold UWCCC accountable to the PED. The DWETC will
monitor the implementation of the PED and will include center members at all ranks, staff, and trainees. To
facilitate our goal of increasing workforce diversity at the UWCCC, we will routinely collect both quantitative and
qualitative information from faculty, staff, trainees, and advisory board members. UWCCC’s PED framework
aligns around four core strategies highlighted in the NIH Scientific Workforce Diversity Toolkit: (1) diversify the
talent pool, (2) create unbiased talent searches, (3) drive outreach and networking for recruitment, and (4) foster
mentoring relationships for advancement and retention. To develop a more diverse and inclusive UWCCC, we
will leverage existing programs across our institution and implement new steps within our center to ensure that
the systems for education, mentoring, and career advancement are led with DEI principles. We will achieve our
aims by using evidence-based approaches to recruit and retain diverse individuals, implementing practices to
prepare members for leadership roles, expanding the workforce pipeline, and leveraging multiple institutional
resources and programs from across the UW campus. A new DEI-specific strategic plan will ensure integration
of DEI initiatives across UWCCC and UW Health while incorporating the voices of PED leaders, the DWETC,
the COE Office, the CTREC, and UWCCC’s Community Advocacy Boards. Through planning and executing our
plan to enhance diversity, we will ensure that the benefits of the research, clinical care, and education at the
UWCCC will align with the Wisconsin Idea to benefit all households in the state and beyond.

Public health relevance
PROJECT NARRATIVE Per PAR-21-321 instructions, this component is not required.